Tolerance and Physical Dependence after Chronic Benzodiazepine Treatment

Although benzodiazepines (BZs) are considered to be among the safest prescription drugs in modern medicine, their utility is constrained by a number of side effects, including the liability for dependence, and recent epidemiological research suggests BZ abuse is on the rise in the U.S. The overall goal of this application is to investigate the extent to which GABAA receptor subtypes are differentially involved in tolerance and physical dependence associated with long-term BZ exposure, using relevant nonhuman primate models. This new application builds on research that has implicated unique roles for α1, α2, α3, and α5 subunit-containing GABAA receptors (α1GABAA, α2GABAA, α3GABAA α5GABAA receptors, respectively) in the abuse-related and therapeutic effects of BZs. As part of a previous grant, we obtained several key preliminary findings: (1) tolerance may develop rapidly to behavioral effects associated with α1GABAA receptors, but not α2/3GABAA receptors; and (2) the ability of BZ-type drugs to induce physical dependence may involve α1GABAA receptors. Together, these findings support the working hypothesis that α1GABAA receptors are key mediators of both tolerance and physical dependence associated with chronic exposure to BZ-type drugs. However, the extent to which α2GABAA, α3GABAA, and α5GABAA receptors are involved in tolerance and physical dependence remains unclear. In Specific Aim 1 we will evaluate the extent to which tolerance and physical dependence will be induced by chronic treatments with the sedative/anxiolytic BZ, alprazolam (Xanax), the most commonly-abused BZ. Following 30 days of exposure, we will evaluate differential tolerance to behavioral effects, including self-administration, as well as assess spontaneous and precipitated withdrawal. In Specific Aim 2, we will evaluate the hypothesis that α1GABAA and α5GABAA receptor subtypes mediate tolerance, whereas α1GABAA receptor subtypes mediate physical dependence induced by BZs. Using the parameters established in Aim 1, we will conduct studies with a novel series of ligands that are agonists or antagonists with selectivity for α1GABAA, α2GABAA, α3GABAA, and α5GABAA subtypes. We hypothesize that tolerance development requires co-activation of both the α1GABAA and α5GABAA receptor subtypes and that physical dependence involves the α1GABAA receptor subtype. The research in this new application addresses a key topic for public health by systematically exploring the role that receptor subtypes play in the behavioral effects of chronic exposure to BZ-type drugs. Innovation of this proposal is in (1) the use of rigorous quantitative behavioral models of chronic physical dependence in a species with high translational validity (rhesus macaque); and (2) the use of first-in-kind BZ ligands with unique subtype selectivity.

Public health relevance
Valium, Xanax, and related drugs, referred to as “benzodiazepines” are prescribed widely for the treatment of anxiety disorders, one of the most common psychiatric disorders in the U.S. Benzodiazepines are considered to be among the safest prescription drugs in modern medicine, but they unfortunately are also drugs of abuse. The overall goal of this application is to uncover mechanisms that underlie long-term exposure to benzodiazepines, namely tolerance and withdrawal, in order to develop safer and more effective medications.